Novel Analogs for Tauopathies and Their Mode of Action

Project Abstract and Summary Alzheimer’s disease (AD) is a progressive neurodegenerative disease and is considered the predominate cause of dementia worldwide. In the United States (US), it is the sixth leading cause of death. It results in a loss of memory, thinking skills and task performance. The pathological hallmarks of AD are accumulated amyloid β (Aβ) plaques and neurofibrillary tangles (NFTs). Studies have shown that reduction in wild-type tau prevents Aβ-dependent behavioral and cognitive deficits, suggesting that therapeutic interventions that alter the levels of tau may be beneficial. Our lab provided convincing evidence that either silencing the Sp1 gene, using small interfering RNA, or treatment of animals with Tolfenamic Acid (TA), lowers the expression of AD-related Sp1 target genes. TA (Clotam® Rapid) is currently used in Europe and other countries to treat symptoms of migraine headaches. TA serves as an excellent candidate for the design and synthesis of novel derivatives. Thus, we synthesized a series of analogs using the lead compound scaffold by focusing on optimizing potency, selectivity, and generating drug-like molecules for CNS delivery, while, also, honing the physical properties of the compounds. Furthermore, we aimed to decrease the COX-related action of these compounds and enhance their targeting of Sp1/tau. We, now, have a series of compounds and we would like to examine: efficacy, potency, cytotoxicity, potential mechanism of action, selectivity and off target effects in an in vitro cell culture model. The following are the aims of the proposal: 1) Investigate the ability of analogs, with a better safety profile than TA, to lower the mRNA and protein levels of total tau, site specific tau phosphorylation, CDK5, Sp1, and COX2, in an in vitro model, 2) Testing of lead analogs for mode of action and target engagement, 3) Analyze the brain transfer potential of TA analogs using in silico and in vitro approaches. The expected outcomes are that we will find that TA analogs specifically target Sp1 and other related biomarkers by chelating Zn. We, also, expect that the analogs will cross the blood brain barrier (BBB) due to structural and physiochemical characteristics that enhance brain penetration potential.

Public health relevance
Project Narractive Alzheimer’s disease is the sixth-leading cause of death, in the US, and is the only top 10 leading cause of death that can’t be cured, prevented or slowed. Tolfenamic Acid (TA) has been shown to lower transcriptional biomarkers related to AD and other taupathies. Since, TA has, already, been designated by the FDA and EMA as an orphan drug for the treatment of frontotemporal dementia, it is an ideal drug prototype that can be used to synthesize analogs with better efficacy, specificity and less toxicity.